Disparities in Cancer Outcomes from the COVID-19 Pandemic

PROJECT SUMMARY
Background: A nationwide moratorium was instituted on all elective clinical services in March 2020 to slow the
transmission of COVID-19, safeguard patients, and preserve healthcare resources. This led to a major
disruption in cancer screening and diagnostic procedures. Among Veterans nationwide, we found a significant
and persistent decrease in the detection of new cancers. Without routine screening and easy access to
medical care, cancer patients may go undetected, only presenting when the cancer is beyond curative therapy.
The unprecedented COVID-related disruptions may also have exacerbated preexisting disparities in cancer
outcomes among disadvantaged populations.
Significance: With no information on the impact of the COVID-19 pandemic on cancer outcomes or changes
in outcome disparities, health systems cannot identify populations at risk or implement programs to mitigate
current deficits. We need a comprehensive evaluation of how pandemic disruptions to cancer care are
affecting cancer outcomes. In addition, we need a surveillance system to assess changes in cancer outcomes
over time, as the impacts of the pandemic evolve and mitigation efforts are implemented. We hypothesize that
cancer outcomes in the COVID era will worsen, with higher rates of 1) mortality, 2) cancer recurrence, and 3)
metastatic disease at presentation. Additionally, disparities in the above outcomes will be exacerbated in the
COVID era among patients in the following vulnerable subgroups: female, age > 60 years, Black, Latino, rural,
or in zip codes with lower SES. We will evaluate these hypotheses through the following Specific Aims: 1)
Identify differences in cancer outcomes between the COVID and pre-COVID eras by cancer type. 2) Identify
disparities in cancer outcomes among disadvantaged populations in the COVID era.
Methodology: Using detailed, nationwide, patient-level data from the Veterans Administration Informatics and
Computing Infrastructure (VINCI), we will evaluate changes cancer outcomes from the pre-COVID (March 1,
2018 through February 29, 2020) to COVID (March 1, 2020 to February 28, 2025) era. Poisson and Cox
Proportional Hazards models will be used to analyse the change from the pre-COVID to COVID era by cancer
type and among vulnerable subgroups.
Next Steps/Implementation: The VINCI dataset offers a unique opportunity to provide near real-time
assessment of the impacts of ongoing disruptions in new cancer identification on cancer outcomes and the
exacerbation of existing disparities in a healthcare crisis. This project will allow us to develop actionable data
and a system of surveillance to guide interventions that address the identified disparities. Using the validated
system developed in this project, we will expand to populations outside of the VA and initiate interventional
studies to mitigate or eliminate the identified disparities.

Public health relevance
PROJECT NARRATIVE The COVID-19 pandemic has created unprecedented disruptions in cancer care, and patients with cancer who have slipped through the system unidentified will present with late-stage disease that is too advanced for curative treatments. While studies have demonstrated deficits in new cancer diagnoses, healthcare leaders and policymakers have no data on the impact of these deficits on cancer outcomes or outcome disparities exacerbated in already vulnerable populations. We propose a comprehensive evaluation of this evolving crisis and a framework for systematic surveillance of changing cancer outcomes and disparities.